Unraveling the Locus Coeruleus Circuitry in Opioidinduced Sleep Disturbances

PROJECT SUMMARY
The main goals of this training proposal is 1) to provide Li Li, MD, PhD, a practicing anesthesiologist at the
University of Washington, with additional scientific and professional skills to facilitate his transition to become an
independent investigator, and 2) to better understand how the locus coeruleus (LC), at the cellular and circuit
levels, contributes to opioid-induced sleep disturbances. Studying sleep disturbances caused by opioids is
important because opioids have enormous societal impact, causing over 46,000 overdose deaths in 2018 and
almost $80 billion in economic cost annually in the United States; and because recent studies have implicated
several aspects of sleep disturbances caused by opioids, including poorer cognition, decreased pain tolerance,
and increased negative affect, in contributing to chronic opioid use and relapse. Interestingly, the LC and
paraventricular thalamus (PVT) are two brain regions that modulate sleep-wake balance and mediate withdrawal
behaviors from opioids, but their roles in opioid-induced sleep disturbances are relatively unknown. Thus, during
his K99 phase, Dr. Li aims to 1) examine LC neuronal activity in relation to sleep patterns in a mouse model of
acute and chronic opioid administration and 2) determine the role of local opioid receptors in the LC in opioid-
induced sleep disturbances. Furthermore, he plans to receive training in 1-photon microendoscopic imaging,
optogenetic manipulation of opioid receptors, and cell-specific drug targeting using drug acutely restricted by
tethering (DART); and will be mentored by Prof. Michael Bruchas, a world-renowned expert in opioid
neurobiology, and a committee of experts in neural circuitry analysis, sleep, and substance abuse disorders.
Together, his training will help transition to his independent R00 phase, where he plans to use his trained skills
1) to examine PVT neuronal activity in relation to sleep patterns in acute and chronic opioid administration, and
to determine role of local opioid receptors in PVT in opioid-induced sleep disturbances. Studies in the
independent phase will prepare him for a future R01 submission to further examine arousal neural circuitry
response to sedative and anesthetic drugs. Thus, this proposal aims to characterize the LC-PVT circuit in a
mouse model of acute and chronic opioid administration using cutting-edge tools in neural circuit analysis and
cell-specific pharmacology in order to better understand the cellular and circuit mechanism underlying opioid-
induced sleep disturbances, and provides the essential training and mentorship for Dr. Li to help him achieve his
career goal of starting his own lab and becoming an independent investigator.

Public health relevance
PROJECTIVE NARRATIVE Despite the opioid epidemic causing over 46,000 overdose deaths in 2018, opioids remain important drugs for treating acute pain after surgery, and consequently put surgical patients at risk for their myriad of side effects and for chronic opioid use. As recent studies have implicated opioid-induced sleep disturbances as a contributing factor to opioid dependence and relapse, the proposed studies aim to better understand the neurobiological mechanism by which opioids disrupt sleep acutely and chronically. Together, these new findings may offer a new approach in treating those suffering from opioid addiction, and new insights into the role of acute opioid use in sleep disturbances after surgery.